Project 1 Title: Gut microbial metabolites as drivers of ethanol-induced liver injury

ABSTRACT
Recent evidence has emerged that microbes resident in the human intestine represent a key transmissible
environmental factor contributing to a number of human diseases. However, mechanisms by which gut
microbial-derived factors signal to the host to promote these diseases are largely unknown. We have recently
discovered a metaorganismal pathway where nutrients present in high fat foods (phosphatidylcholine, choline,
and L- carnitine) can be metabolized by the gut microbial enzymes to generate trimethylamine (TMA), which is
then further metabolized by the host enzyme flavin-containing monooxygenase 3 (FMO3) to produce
trimethylamine-N-oxide (TMAO). Here we show that pharmacologic inhibition of the gut microbial choline TMA
lyase enzyme CutC/D protects mice against alcoholic liver disease. Unexpectedly, this protection is associated
with reorganization of the host circadian clock. Our specific aims are: Aim 1. Testing the hypothesis that
alcohol-induced circadian disruption depends on gut microbial TMA production, and that TMA lyase inhibitors
represent a gut microbe-targeted chronotherapy; and Aim 2. Testing the hypothesis that the microbe-derived
metabolite TMA activates the host G protein-coupled receptor trace amine-associated receptor 5 (TAAR5) to
Promote Ethanol-Driven Sarcopenia. These studies will be significant because they have the potential to
uncover the first ever described diet-microbe-derived zeitgeber. Successful completion of this project will be
transformative by providing proof of concept that a non- antibiotic drug targeting a specific microbial enzyme
can serve as a therapeutic strategy for alcohol-induced tissue injury.